METABOLIC BONE DISEASE

Adults and children with generalized skeletal abnormalities or abnormalities in mineral metabolism have been studied. Included were metabolic, radiographic, genetic and pathological studies to define the pathogenesis of a variety of disorders of bone and mineral metabolism. particularly osteoporosis, osteomalacia and Paget's disease. Several new disorders have been characterized.